Neural systems controlling the inhibition of heroin seeking

Relapse to heroin use remains a significant challenge in the treatment of heroin addiction, yet our
understanding of those neural systems that enable individuals to inhibit heroin seeking and relapse remains
poor. The long-term goal of our laboratory is to identify the neural circuits and the changes in those circuits that
underlie the inhibition of heroin-seeking behavior, using rat models of heroin seeking. Previous work with
cocaine seeking has suggested that the infralimbic cortex is involved in the extinction and inhibition of cocaine
seeking. Yet, the role of this prefrontal region in opioid seeking has been unclear, as studies have produced
findings indicating that the infralimbic promotes and inhibits opioid seeking. As increasing evidence suggests
that different projections from prefrontal regions can mediate distinct functions, we have hypothesized that the
ability of the infralimbic to either promote or inhibit heroin seeking is related to the specific projections from this
region to the nucleus accumbens shell (NAshell) vs. the amygdala. In addition, we have recently developed
preliminary data suggesting that the anterior portion of the insular cortex (rostral agranular insular cortex,
RAIC) inhibits heroin seeking. However, other studies with other drugs of abuse indicate that the RAIC also
appears to promote drug-seeking behavior. Thus, it seems likely that, as with the IL, the key to understanding
the role of the RAIC in heroin seeking depends on targeting different projections. Indeed, like the infralimbic,
the RAIC projects to the amygdala, a region that prior studies have found to be involved in promoting
reinstatement to heroin seeking. However, the RAIC also provides an input to the infralimbic itself, thus
providing a mechanism for how the RAIC may influence and interact with the infralimbic during the extinction
and inhibition of heroin seeking. The proposed studies, therefore, will examine these circuits during heroin
seeking and will include approaches that have not, to our knowledge, been used in studies of heroin seeking.
In particular, our studies will examine the neurophysiological correlates of heroin seeking in the RAIC and IL
via ensemble recordings in both regions simultaneously. The findings from this work will likely reveal neuronal
subpopulations in both regions related to the extinction and/or inhibition of heroin seeking. Moreover, our
proposed work will use optogenetic and chemogenetic manipulations of the specific projections from the
infralimbic to the NAshell and amygdala and from the RAIC to the infralimbic cortex and amygdala. Specifically,
these manipulations will allow us to interrogate the role of each pathway in the encoding of the extinction
learning and the reinstatement of heroin seeking. As a result, this proposal will provide converging lines of
evidence regarding this circuitry and the inhibition of heroin seeking. The findings from the studies will furnish
critical new basic knowledge of the neural systems underlying the suppression of heroin seeking that will
potentially lead to the development of more effective treatments that strengthen such systems in heroin-
addicted individuals.

Public health relevance
Public health relevance: Opioid addiction has grown into a major epidemic in the United States, as individuals addicted to opioids, including heroin, face great difficulty in suppressing their drive to consume the drug, even long after their previous use of their drug. The proposed studies will focus on understanding those neural systems that underlie the suppression and inhibition of heroin seeking. The findings of this work may have significant future benefit in the creation of better treatments that strengthen the ability to inhibit heroin use.